Whole-genome sequencing study of alcohol use disorder across biobanks and ancestries

Abstract
Alcohol use disorder (AUD) is a leading cause of death and disability worldwide. A deeper understanding of the
genetic mechanisms underlying AUD could significantly improve the diagnosis, prevention, and treatment,
thereby reducing the burden of AUD-related problems. Although genome-wide association studies (GWAS)
have identified a growing number of genetic variants and pathways associated with AUD, key gaps remain
unaddressed. First, current GWAS predominantly focuses on common variants, neglecting rare and structural
variants due to technical limitations. Second, the top associated variants identified in GWAS loci may not be
the true causal variants driving AUD risk. Third, another critical gap lies in the limited predictive performance of
polygenic risk score (PRS) for AUD based on GWAS common variants. Fourth, the expression perturbation in
specific cell subtypes or cellular processes in the human brain affecting the AUD risk is poorly understood. To
address these gaps, we propose this innovative study leveraging large-scale whole-genome sequencing
(WGS) data from biobanks, publicly available single-cell RNA sequencing (scRNA-seq) data in brain cells, and
state-of-the-art statistical methods to improve the understanding of AUD genetics, response to the Notice of
Special Interest: Secondary Analyses of Existing Alcohol Research Data (NOT-AA-23-011). It aims to uncover
novel rare, common, and structural variants associated with AUD and recover the missing heritability (Aim 1);
identify causal variants through cross-ancestry fine-mapping and improve disease prediction using a novel
whole-genome PRS framework (Aim 2); and map the WGS results to existing scRNA-seq data to identify key
brain cell subtypes and processes involved in AUD (Aim 3). The proposed research is timely and in line with
NIAAA’s mission, promises to substantially enhance our understanding of the genetic architecture of AUD, and
will lay the foundation for developing precision interventions to prevent and treat alcohol-related diseases.

Public health relevance
Project Narrative While GWAS findings have significantly advanced our knowledge of the genetics of AUD, gaps remain in applying the findings clinically. Unlike conventional studies, this study will take advantage of existing large- scale WGS datasets to find novel rare, common, and structural variants associated with AUD and recover the missing heritability, improve causal variant identification and disease prediction using a novel whole-genome polygenic risk score framework, and identify cell subtypes and key cellular processes in the human brain using published scRNA-seq data. This study will be the first and most comprehensive multi-ancestry WGS study to investigate the full genetic architecture of AUD.